THE OBJECTIVE OF THIS CONTRACT IS TO PROVIDE AND MAINTAIN THE INFRASTRUCTURE FOR DISTRIBUTION OF LIVER TISSUES PREVIOUSLY COLLECTED BY THE CURRENT LIV

THE OBJECTIVE OF THIS CONTRACT IS TO PROVIDE AND MAINTAIN THE INFRASTRUCTURE FOR DISTRIBUTION OF LIVER TISSUES PREVIOUSLY COLLECTED BY THE CURRENT LIV